IL13 - A Novel Therapeutic Factor for Cardiac Regeneration

PROJECT SUMMARY/ABSTRACT
Organisms such as zebrafish and neonatal mice are capable of complete heart regeneration following partial
amputation. Although adult humans and adult mice lack this cardiac regeneration response, there is great
interest in understanding how heart regeneration can occur in lower organisms so that we can activate these
processes in humans to better treat patients following myocardial infarction (MI). Cytokines and growth factors
play a significant role in the initiation of tissue and organ regeneration in large part by directly stimulating
proliferation of resident cells, or by recruitment and activation of wound healing inflammatory cells. The type II
cytokine Interleukin 13 (IL13) activates pro-proliferative signaling molecules (e.g. AKT and ERK1/2) in both
neonatal and adult CMs and stimulates cardiac myocyte cell cycle activity via signaling through the
IL13Rα1/IL4Rα receptor heterodimer. Subsequent in vivo studies show that IL13 genetic deletion decreases
CM cell cycle activity and abundance of M2-like immune cells, and inhibits heart regeneration in neonates,
while administration of recombinant IL13 is capable of promoting CM cell cycle activity and extending the
neonatal regenerative window. Here, we propose to identify the cellular mechanisms by which IL13 promotes
heart regeneration post MI in neonatal mice and test the extent in which these mechanisms exist in the adult.
Aim 1 tests the hypothesis that IL13 signals directly on CMs via the IL13Rα1/IL4Rα receptor to promote
cytokinesis of pre-existing CMs and heart regenerating in the neonate and adult. Aim 2 will investigate the
cellular source of IL13 following MI at neonatal and adult stages and will test the hypothesis that IL13 promotes
tissue resident macrophage polarization via IL13Rα1/IL4Rα signaling and these macrophages facilitate post MI
healing in the neonatal, but not the adult heart. Collectively, the proposed experiments will determine the cell
type specific mediators of IL13 signaling during neonatal regeneration and will assess the preservation, or
absence, of these mechanisms in the adult. By comparing the IL13-depentent mechanisms in CMs and the
immune system that differentiate the regenerative (neonatal) and non-regenerative (adult) mouse heart, we
aim to identify actionable pathways for augmenting regenerative capacity in the adult heart.

Public health relevance
PROJECT NARRATIVE Regenerative treatments for patients suffering from heart failure could be enabled by understanding and re- activating endogenous mechanisms of heart regeneration in lower organisms. The proposed research uses rigorous approaches to investigate the mechanisms by which Interleukin 13 stimulates neonatal mammalian heart regeneration and tests weather these pathways can be stimulated to promote adult mammalian heart regeneration. Mechanisms elucidated in this proposal can potentially be harnessed to facilitate adult cardiac regeneration in the future.